Patient Specific 3D Printed Diabetic Insoles to Reduce Plantar Pressure

It is estimated that, globally, a lower extremity amputation takes place every 30 seconds, and that 85% of
these amputations are the result of diabetic foot ulcers. Plantar foot ulcers develop, in part, due to high
loading and mechanical stress to the soft tissues of the foot. Custom standard of care insoles aim to reduce
regions of the foot that experience excessive plantar pressures by redistributing pressure to other areas.
Limitations in the effectiveness of standard of care insoles, however, result in rates of ulceration that remain
unacceptably high. Meanwhile, a revolution in 3D printing technologies, material properties, and digital
manufacturing pipelines are enabling a wave of innovative solutions that are improving outcomes in many
areas of medicine. We aim to leverage these techniques to create novel patient-specific 3D printed insoles
with personalized metamaterials which we believe will demonstrate superior offloading performance.
Personalized metamaterials are 3D printed materials formed from lattice patterns derived from patient-
specific characteristics, resulting in insoles that are uniquely matched to the patient’s needs. The aim of
this study is to determine if 3D printed insoles with personalized metamaterials reduce plantar pressures
for at-risk areas of the foot better than standard of care insoles. We will manufacture three different insoles,
namely the standard of care (SC), 3D printed pressure based (3DP-PB), and finite element optimized
(3DP-FE) insoles. 3DP-PB insoles will be designed from plantar foot shape and dynamic plantar pressure
while the 3DP-FE insoles will be designed from simulations of participant’s feet interacting with different
insole designs to optimize the insole shape and metamaterial properties. In a repeated measures study,
we will measure peak plantar pressure and pressure time integral for each type of insole with a group of
25 participants who have diabetes and elevated forefoot pressure. We hypothesize that the 3D printed
insoles comprised of personalized metamaterials derived from plantar measurements (3DP-PB) will have
greater reductions in the peak plantar pressure and pressure time integral than the SC insoles (H1).
Additionally, we hypothesize that, relative to the other two insoles, insoles optimized through patient-
specific finite element simulations (3DP-FE) will have the greatest reduction in peak plantar pressure and
pressure time integral (H2). To facilitate the clinical translation of the novel 3D printed insoles we will carry
out focus groups with patients and clinicians to gain their early feedback and insights. Results from these
focus groups will be qualitatively synthesized into actionable improvements to the insoles. Novel insoles
that utilize 3D printing fabrication may provide enhanced protection from foot ulcers that frequently
progress to amputation. Moreover, digital manufacturing technologies and 3D fabrication methods have
relatively low barriers to mass production, which can greatly expedite translation into clinics. The VA is
widely recognized as a leader in health care innovation. The development of custom 3D printed insoles
that may reduce risk for amputation is well-aligned with VA’s spirit of innovation and is supported by the
VA mission “To care for him who shall have borne the battle.” Reducing rates of ulceration in our Veteran
population has the potential to greatly reduce incidence of lower-limb amputations and improve the quality
of life for our Veterans.

Public health relevance
In the US, approximately 90,000 amputations are performed annually as a result of diabetic foot ulceration and the VA currently cares for more than half million Veterans at high risk for amputation. The current standard for prevention of plantar foot ulcers in those individuals is specialty diabetic shoes and custom insoles. The purpose of the custom insole is to cushion the feet, evenly distribute pressures, and to selectively offload areas of increased pressure. Advances in 3D printing, materials, and software have enabled new 3D printed metamaterials whose properties are derived not only from the base material but also from lattice microstructures within the metamaterial. We are proposing to redesign diabetic insoles to use 3D printing with patient specific stiffness and structural behavior. The purpose of this grant is to determine if the 3D printed insoles are better at reducing plantar pressures than the traditional insoles. The results of this study can help reduce annual rates of lower limb loss within our Veteran population.